Brain Mechanisms of Pain Processing and Modulation

Over the last year, the project has been developed, submitted and approved by the Scientific Review Committee, Blue Panel IRB and MRI Safety Committee. We have since been finalizing the experimental procedures, i.e. optimizing the behavioral paradigm and integration of the technical equipment with the MRI environment. Subject recruitment and data acquisition are scheduled to begin in September 2013. The established protocol will investigate brain mechanisms of placebo response in chronic pain. A group of patients with chronic widespread pain (fibromyalgia) will be compared to matched healthy controls. Each subject will participate in two sessions separated by 1-7 days. A total of 44 patients and 44 healthy controls will be recruited. Subjects will be recruited through the NIH Clinical Trial recruiting line, and via advertisements placed around the main NIH campus and in local newspapers. In this randomized double-blinded study, each subject will participate in two sessions separated by 1-7 days. The first session will include familiarization and training using psychophysical methods in a mock scanner environment. The second session will include testing in the MRI environment. During the second session, the effect of intravenous administration of naloxone on the placebo effect will be tested.. Subjects will be randomly assigned to either a saline or naloxone condition. The study will allow us to test the following hypotheses: 1) Healthy individuals will show stronger placebo analgesia than chronic pain patients; 2) there will be a positive correlation between the amount of gray matter reduction in placebo-relevant brain regions and reduction in placebo responsiveness in chronic pain patients relative to healthy subjects; 3) compared to healthy subjects, chronic pain patients will have lower levels of brain activity in placebo-relevant brain regions during periods of anticipation of pain relief and the degree of decreased anticipatory activity will correlate with the decrease in magnitude of placebo analgesia; and 4) blocking endogenous opioid activity, by administering the opioid receptor antagonist naloxone, will reduce placebo analgesia in healthy subjects, but not at all or to a lesser extent in chronic pain patients. Correspondingly, brain activity in placebo-relevant brain regions will be reduced by naloxone in healthy subjects but not in pain patients.